T cell regulation by adult prostate stem cells

Project summary/abstract:
Adult prostate stem cells (PSC) are a rare epithelial progenitor population in the prostate. While essential for
normal homeostasis, they have also been implicated in hyperplasia and cancer initiation.1-7 Inflammation can
fuel hyperplastic diseases through its production of growth factors and cytokines;1, 8, 9 however, the impact of
inflammatory factors on PSC and how PSC interact with infiltrating immune cells is not well studied. To examine
the cross-talk between epithelial PSC and immune cells, the proposed studies will utilize the Prostate Ovalbumin
Expressing Transgenic 3 (POET3), an inducible mouse model of abacterial T cell induced inflammation that
produces epithelial and stromal hyperplasia, functioning as a model for human autoimmune prostatitis.10
Current studies in our lab have taken prostates from inflamed and non-inflamed (naïve) POET3 mice, which
were harvested, digested, and separated by fluorescence-activated cell sorting (FACS) to isolate an enriched
basal PSC population defined as lineage negative (CD45-/CD31-), stem cell antigen-1+, CD49f+ (LSC).11, 12 Single
cell mRNA sequencing comparing freshly isolated LSC from naïve (nLSC) and inflamed (iLSC) mice revealed
differential expression of multiple immune regulatory genes, suggesting a possible role in regulating T cell
response. In vitro suppression assays conducted in our lab confirmed that while neither mature luminal nor nLSC
impacted T cell proliferation, iLSC were able to suppress CD8+ T cells. This effect is independent of recognized
mechanisms, nitric oxide production, IDO1, or PD-L1.13 Notably, prostates from inflamed mice show a marked
enrichment for LSC, suggesting that these cells are protected from T cell attack. Coupled with human BPH data
indicating prominent T cell populations enriched for exhaustion and anergy genes, these findings suggest a
potential novel mechanism of T cell suppression not previously identified in LSC that is induced under
inflammatory conditions, possibly as a tissue protective mechanism.
Thus, we hypothesize that adult basal prostate stem cells are able to harness immune regulatory capabilities
to suppress T cell function and survive T cell mediated attack. Using the POET3 model of autoimmune
inflammation and human BPH samples, studies described herein will explore the T cell suppressive factors
utilized by PSC in vitro and evaluate the impact of PSC suppression in vivo.
The resulting data will provide a foundation for more thorough study of rare stem/progenitor cells in immune
regulation while shedding light on their contribution to epithelial hyperplasia during inflammation.

Public health relevance
Project narrative: The proposed studies will improve our understanding of the crosstalk between epithelial stem cells and T cells. Using a mouse model of abacterial prostate inflammation, the proposed studies in the first aim will identify key immunosuppressive mechanisms utilized by rare stem cell populations to survive under the inflammatory conditions of BPH. The second aim will reveal the extent of their immune regulatory abilities and maintained proliferation in the prostate, shedding light on their contributions to epithelial hyperplasia in BPH.